CORE--GLASSWARE WASHING

Description: This facility occupies approximately 200 sq. ft. of space on the eighth floor of the Biomedical Research Building. It comprises three pieces of equipment dedicated to providing glassware cleaning to nine funded projects. The equipment consists of an Amsco model 570 glassware washer, an Amsco model 1024 glassware dryer, and a Gettings Novus I autoclave. Washing is done exclusively with deionized water. The equipment was originally purchased by the University of Colorado for use by the MRRC.